PURPOSE: Positively Uniting Researchers of Pain to Opine, Synthesize, and Engage

Research shows that diverse teams working together and capitalizing on innovative ideas and distinct
perspectives outperform homogenous teams. The Interagency Pain Research Coordinating Committee
(IPRCC) has determined that basic, translational, and clinical researchers do not regularly collaborate
when developing grant applications; and that if pain management researchers across all disciplines were
to work together, it would enhance the innovation, relevance, and practical application of pain
management research. Positively Uniting Researchers of Pain to Opine, Synthesize, and Engage
(PURPOSE) will foster and support constructive and dynamic interprofessional communications and
collaborations between pain research across the continuum of basic, translational, and clinical research.
PURPOSE utilizes an approach to interprofessional practice and education that has achieved a similar
cultural transformation for a comparable multi-professional audience; the technological infrastructure to
support it, including a customized, contemporary online and mobile networking, learning, and collaboration
space; and the interrelated program planning elements and systems to develop and implement these
elements. PURPOSE will create, support, and continually refine an annual conference and online
networking community, to support the careers and research of pain researchers from across the
continuum of basic, translational, and clinical research, and who hail from diverse, multidisciplinary
backgrounds. To include and support a diverse network, PURPOSE has established and will continue to
develop strategic outreach partnerships to recruit and support the unique needs of researchers from
across the continuum of basic, translational, and clinical research, and researchers from historically under -
represented demographics, including women, Black, LatinX, and communities of color, LGBTQ and neuro -
diverse researchers including researchers who identify as being on the autism spectrum. Training and
development will include affective understanding as to the human impact of the problems to which
researchers seek answers by involving patients with the lived-experience of daily high-impact chronic pain
in the direction, goals, and activities of the program overall.

Public health relevance
PURPOSE (Positively Uniting Researchers of Pain to Opine, Synthesize, and Engage) will create, support, and continually refine an annual conference and online networking community, to support the careers and research of pain researchers from across the continuum of basic, translational, and clinical research, and who hail from diverse, multidisciplinary backgrounds.